Identifying a Role for Vasoactive Intestinal Peptide Expressing Interneurons in a Mouse Model of Dravet Syndrome

PROJECT SUMMARY: I am applying for this NRSA fellowship as an MD/PhD student with the long-term goal of becoming a successful physician scientist running my own translational neuroscience research lab. This project is designed to give me the training and experience required towards achievement of this goal. The goal of the project is to investigate the mechanisms of epilepsy and cognitive impairment in Dravet syndrome. Dravet syndrome is a severe neurodevelopmental disorder of childhood defined by epilepsy and autism that is currently without cure or disease-modifying therapy. This syndrome is caused by mutations in the gene SCN1A, which codes for the voltage gated sodium channel alpha subunit Nav1.1. Based on work in a mouse model of Dravet Syndrome, it is hypothesized that GABAergic interneurons — particularly the subsets marked by expression of parvalbumin (PV-INs) and somatostatin (SST-INs) — are selectively impaired, while excitatory glutamatergic neurons are not affected. Interneurons are classically considered to be inhibitory, so loss of Nav1.1 in interneurons is thought to cause decreased inhibition in the developing brain with resulting cognitive impairment and epilepsy. However, interneurons are incredibly diverse in terms of gene expression, morphology, electrophysiological properties, and synaptic connectivity. Interneurons marked by expression of vasoactive intestinal peptide (VIP-INs) constitute a third prominent subset of interneurons that form distinct disinhibitory circuits by primarily targeting other interneurons, and thereby regulate cognitive processing, attention, and learning, functions which are impaired in Dravet Syndrome. However, no previous study has investigated whether VIP-INs are impaired in this model. I show preliminary data indicating that VIP-INs do express Nav1.1 and have impaired excitability in a mouse model of Dravet Syndrome. I hypothesize that this leads to dysfunction of disinhibitory microcircuits that underlie sensory processing and brain state modulation. In Aim1, I use slice electrophysiology, immunohistochemistry, and pharmacology to show that VIP-INs in fact express Nav1.1 and are functionally impaired in Dravet syndrome mice. In Aim 2, I will investigate the effect of VIP interneuron dysfunction on the activity of a specific sensorimotor circuit in Dravet Syndrome mice using optogenetics and synaptic physiology. Finally, in Aim 3, I will use two-photon calcium imaging to study cortical dynamics that depend on VIP-IN activity in awake behaving DS mice in vivo. Results will implicate VIP-IN dysfunction in the pathogenesis of Dravet syndrome and suggest novel avenues for therapy.

Public health relevance
PROJECT NARRATIVE: Dravet syndrome is a severe neurodevelopmental disorder characterized by epilepsy, cognitive impairment, and sudden death, that is without effective treatment or cure. Study of this ion channelopathy offers an opportunity to understand the mechanisms by which mutations in individual ion channels can produce complex neurological phenotypes such as epilepsy and autism. My work using cellular and synaptic physiology, pharmacology, molecular biology, optogenetics, and in vivo calcium imaging, will link across levels of analysis, from ion channel mutation to interneuron dysfunction, interneuron-mediated circuit disruption, and cognitive impairment, while illuminating a new potential therapeutic locus for the treatment of Dravet syndrome.